EMOTIONAL DISTRESS, NATURAL IMMUNITY IN GYNECOLOGIC CANCERS

This study is designed to examine the relationships between psychological distress, natural killer cell cytotoxicity, and disease progression in women with gynecological cancer.